Role of TLR7/8-activating microRNAs in fetal inflammatory response syndrome

Preterm birth is commonly associated with chorioamnionitis; infection/inflammation of the fetal membranes (FM).
Pathogens contributing to this do not typically cross the placenta. However, abnormal maternal and/or placental
immune responses can cause inflammation in the fetus, contributing to Fetal Inflammatory Response Syndrome
(FIRS). FIRS is a systemic activation of the fetal immune system associated with fetal injury and lifelong health
issues. The mechanisms by which maternal/placental immune responses induce fetal inflammation, the method
of communication between mother and fetus, and the breadth of fetal developmental consequences are not fully
understood. FMs generate inflammatory responses to infections through activation of Toll-like receptors (TLRs).
A novel family of microRNAs (miRs) can induce sterile inflammation through the ssRNA sensors, TLR7 and
TLR8. We found an intermediate role for TLR7/8-activating miR-146a-3p in driving FM inflammation via TLR8,
downstream of TLR4 activation by bacterial LPS. In preliminary studies, we found TLR7/8-activating miR-21a
and miR-29a are elevated in exosomes released from bacterial LPS- and viral Poly(I:C)-stimulated human FMs,
and in amniotic fluid exosomes of pregnant mice exposed to LPS. Preliminary data also show maternal exposure
to LPS increases fetal brain, tail, and gut inflammatory IL-1b and KC (IL-8) in wildtype (WT) mice but not in TLR7-
/-/TLR8-/- mice. Thus, our central hypothesis is that maternal infection induces FMs to release exosomes
containing TLR7/8-activating miRNAs into the amniotic fluid which drive sterile fetal inflammation via TLR7/8
signaling. This leads to FIRS and subsequent developmental consequences. We will determine if: FM/amniotic
fluid-derived exosomes containing TLR7/8-activating miRs mediate sterile fetal inflammation (Aim 1); Fetal
inflammation, injury and altered development after a maternal infection is dependent on exosomes causing fetal
TLR7/8 signaling (Aim 2); and Exosomes carrying TLR7/8-activating miRs traffic via the amniotic fluid to cause
fetal inflammation and injury through initial contact with the fetal skin and gut (Aim 3). During the first two aims,
the PI will gain valuable training and experience in various in vitro, ex vivo and in vivo models along with mouse
fetal manipulations, exosome biology, and fetal immune and organ development (K99 Phase). Under the
guidance of her primary mentor, Dr Vikki Abrahams, her expert mentorship and advisory teams, and exceptional
training resources at Yale University, the PI is well positioned to establish herself as an independent investigator
in Reproductive Immunology following her K99 training phase. After securing a faculty position and transitioning
to the R00, the PI will use her newly acquired skills and expertise to study maternal/fetal exosome trafficking and
TLR7/8-activating miR function and signaling in vivo at her new institution. The proposed studies are significant
because they will establish a role for exosomes and TLR7/8 signaling in the initiation of sterile fetal inflammation
and its subsequent impact on fetal/neonatal development, providing critical insight into the mechanisms
underlying FIRS for future work in prevention, treatment, and advancement of maternal/fetal medicine.

Public health relevance
PROJECT NARRATIVE This project aims to understand the mechanisms by which fetal inflammatory response syndrome arises and how this impacts fetal development in the absence of pathogen transfer the mother. Specifically, the proposed studies will investigate the novel role of fetal membrane-derived exosomes containing Toll-like receptor 7 or 8 activating microRNAs in propagating fetal inflammation in the context of a maternal infection using a combination of in vitro and in vivo models. Results from this project will further the scientific understanding of how fetal inflammation arises and how it impacts fetal development, and will help identify novel signaling pathways for potential diagnostics or treatments.